CRCNS: investigating perceptual processing speed and its impact on choice behavior

Project Summary/Abstract
The goal of this project is to investigate the neural mechanisms whereby perceptual information guides the
choice of where to look next; speciﬁcally, we propose to record neuronal activity during urgent decision making
to examine with ﬁne temporal resolution how perception informs motor planning. Neuroscientists normally
study choice behavior with tasks in which a perceptual judgment is made and is followed by a motor report, but
this approach has limitations. First, it allows various covert factors such as attention, anticipation, or task difﬁ-
culty to be traded against each other, creating ambiguities that cannot be resolved via standard psychophysical
metrics, i.e., reaction time and choice accuracy. And second, serialization suppresses the rapid, reciprocal inter-
action between perceptual analysis and motor planning from which informed saccadic choices normally arise.
Our approach is based on a recently developed task in which decisions are urgent and both of these problems
are minimized. Our framework also includes a heuristic, physiologically grounded model that reproduces the
subjects' rich behavior with great detail. Thus, we propose to study how perception informs motor planning
using time pressure to engage these processes within their natural time scale and dynamics, and relate them
quantitatively to psychophysical performance. Oculomotor activity will be recorded from monkeys trained to
perform several variants of our urgent choice paradigm. In Aim 1 we will investigate the relationship between
exogenous (or bottom-up) attention and motor planning by varying the relative salience of target and distracter
during an urgent choice. We hypothesize that the reﬂexive, salience-driven form of attention acts through two
speciﬁc mechanisms: acceleration of ongoing motor plans that are spatially congruent with it, and halting of
those plans that are spatially incongruent. In Aim 2 we will investigate the relationship between attention,
motor planning, and accumulation of sensory evidence by training monkeys to perform an urgent version of
the well known random-dot motion discrimination task. In this case, because the locations of the two choice
targets are dissociated from that of the stimulus to be discriminated, we expect to observe a tradeoff between
stimulus-driven activity (signaling the deployment of attention to the stimulus) and target-driven activity (sig-
naling the impending eye movement). Our previous and current preliminary results indicate that we will be
able to resolve exquisitely orchestrated interactions between perceptual signals and ongoing motor activity that
unfold very rapidly, within a few tens of ms, and are otherwise experimentally inaccessible. We will exploit
this capability to draw essential functional distinctions between the frontal eye ﬁeld (FEF) and the lateral intra-
parietal area (LIP), and to determine the distinct contributions of classical cell types (visual, visuomotor, and
motor) to perceptually guided choices within each of these key oculomotor structures. This work will provide
critical insight about how perceptual information is dynamically incorporated into ongoing motor activity, and
how this interaction determines saccadic-choice performance.

Public health relevance
Project Narrative To return a 130 mph serve, a tennis player needs to prepare to strike the ball early, before it is actually in motion, and analyze the ball's trajectory very rapidly (within 400 milliseconds approximately). We propose a series of experiments to investigate how motor preparation and perceptual processing interact and determine the per- formance of a subject during an urgent decision-making task, and how the activity of nerve cells in the cerebral cortex contributes to these two crucial functions, i.e., analyzing visual stimuli and generating motor actions in response to them. The results will help us characterize the mechanisms that the brain uses to make choices, and this, in turn, will help us understand anomalous behaviors in which those mechanisms malfunction, such as risky decision making, proneness to distraction, and emphasis on instant gratiﬁcation over long-term gains.